Multidisciplinary Research Training in Cardiovascular Disease

PROJECT SUMMARY
The successful sequencing of the human genome and the evolution of human health services research in the
post-genomic era combined with startling advances in imaging technology have offered unprecedented
opportunities to transform patient care in cardiovascular diseases. Over the past decade, Weill Cornell Medicine
(WCM) has made major investments in biomedical research, as well as research training and infrastructure.
WCM requests support for the research training of 4 clinical and non-clinical postdoctoral fellows in a new
multidisciplinary research training program (MRTP) in Cardiovascular Disease, with WCM providing funding for
an additional training slot. The objective is to recruit outstanding candidates with solid foundations in basic
science and/or clinical research and train them to apply their knowledge and skills towards addressing important
clinically unmet needs in the prevention, diagnosis, and treatment of patients with cardiovascular diseases.
MRTP trainees will receive program support for 3 years during which they will follow a structured and rigorous
postdoctoral training program. The MRTP will be a joint effort of 20 eminent preceptors from WCM, Memorial
Sloan Kettering Cancer Center (MSKCC) and the Rockefeller University (RU), which constitute a dense network
of collaborative researchers, who are international leaders in fields directly relevant to cardiovascular physiology
and disease. These preceptors have been organized into 2 themed, but interconnected units of research training:
molecular and cell signaling and cardiovascular imaging. These training units will enable the development of
content-specific educational programming, as well as increase the efficiency administration within the training
program. Oversight will be provided by a Research Training Executive Committee consisting of the Program
Director and two Associate Program Directors, who will also serve as leaders of the training units, as well as 3
additional members who will provide specific guidance on clinical/epidemiologic research, on achieving and
maintaining diversity within the training program, and on mentoring. We have also assembled an outstanding
roster of internal and external advisory board members with a mandate to evaluate the program and provide
specific recommendations to improve both its quality and efficiency. The MRTP's highly personalized training
program will include 1) individual development plans; 2) rigorous research training; 3) hands-on experience in
cutting-edge methodologies; and 4) an integrated curriculum. Trainees will further benefit from the extensive
institutional resources of WCM, MSKCC and RU. Based upon the levels of interest in our fellowship programs,
we anticipate a substantial pool of highly qualified clinical and non-clinical candidates for the proposed MRTP,
which will maintain a strong diversity focus. Through its rigorous, structured and highly personalized curriculum,
this new training program seeks to train future leaders in cardiovascular disease research who are prepared to
translate their findings towards improving patient care.

Public health relevance
PROJECT NARRATIVE This Multidisciplinary Research Training Program in Cardiovascular Disease addresses the critical need for more physician-scientists and scientists focused on cardiovascular physiology and diseases. This Program will provide postdoctoral fellows with rigorous, personalized and state-of-the-art research training. The overarching goal is to equip outstanding young researchers with the knowledge and skills required to accelerate the translation of basic science discoveries into new approaches to the diagnosis and management of cardiovascular disease.